Core A: Administrative Core

PROJECT SUMMARY – CORE A: ADMINISTRATIVE
The Administrative Core A, directed by Dr. Kaufman is an essential component of this Program Project, providing
logistic and strategic support for the Program Advisors and for every Project and Core Leader and coordinating
smooth and regular communication between all the individual components. Core A will facilitate interactions
and synergy between Projects and monitor use of core facilities by the investigators. Core A will manage video
conference access for virtual communication between all sites. We would encourage live meetings, but virtual
meetings will continue to provide better integration and input between the individual components who are not
geographically contiguous. Core A also oversees the distribution of scientific core resources for individual
projects, provides fiscal oversight and ensures SBP and NIH/NCI guidelines compliance by each Project and
Core of the P01. Core A staff will prepare annual budget reports as required by SBP and the NIH/NCI and
coordinate shipments between SBP, UCSD, USC, IDIBAPS, and McGill as required. Core A will coordinate
yearly external and internal board reviews, quarterly P01 Steering Committee meetings and will maintain a
website for the program. Core A will organize monthly meetings for the Working Group and associated scientists.
Finally, Core A will manage a virtual or in person seminar series twice per month in which program members
and invited speakers will present.

Public health relevance
PROJECT NARRATIVE – CORE A: ADMINISTRATIVE The Administrative Core A will provide necessary management to this Program Project by serving as the nexus for communication and coordination of all joint activities between individual Projects, Cores, the Internal and External Advisory Boards and the NCI. The Program seeks to address NCI public health goals by addressing an unmet need in HCC research, which will be supported by Core A by disseminating research results to the health care community. With Core 2, Core A will oversee maintenance of the website and dissemination of results including data exchange. Core A with the Steering Committee will be responsible for evaluating productivity, coordinating efforts, allocating resources, and resolving any conflicts that arise.